Relationship between speech perceptual learning and speech production in Parkinson’s disease

Project Summary/Abstract
In the context of speech-language therapy, Parkinson’s disease (PD) is typically associated with its
consequences on speech production. Interventions generally focus on learning or relearning skills to accomplish
successful production. However, the disease itself, as well as patient responses to interventions, are variable.
Individuals differ widely in how typical their speech output is before intervention and in how much they learn from
treatment. One plausible explanation for this variation comes from a less-studied aspect of speech and language
in PD: speech perception, especially speech perceptual learning. There is a key gap in the PD literature about
whether people who produce atypical rate and intensity properties in their own speech also find it more difficult
to learn rate and intensity properties from others’ speech. There is, therefore, a critical need for a full
understanding of the relationship between speech production and speech perceptual learning in PD. The long-
term goal of this research program is to systematically interrogate the relationship between speech learning and
production in people with PD and to leverage that knowledge to promote effective communication. The overall
objective of this project is to use acoustic measures to determine how challenges with speech perception or
learning can predict individual differences in speech production. The central hypothesis is that individual
differences between people with PD in speech perception or learning can predict individual differences between
people with PD in speech production. This project adopts an individual differences approach to investigate two
major aims: (1) relating individual differences in the perceptual learning of speech rate to the production of
speech rate, and (2) relating individual differences in the perceptual learning of intensity to the production of
intensity. To investigate these aims, each participant will record a speech sample and conduct tasks that involve
learning regularities in rate or intensity in the speech of others. Participants will also complete tasks that require
the ability to distinguish between sentences based on their rate and intensity. Participants’ speech samples will
additionally be judged by naïve listeners to assess the samples’ intelligibility and the effort that it takes to
understand the speakers. If individual differences in perceptual learning predict individual differences in
production, then differences in speech perception may predict differences in speech-language therapy outcomes
that could be targeted to patient needs. A precision medicine approach would allow for interventions that titrate
the amount, level, and type of intervention on an individualized basis to make sure that treatments are focused
on participants who will respond to them in dosages that they will benefit from. For instance, a therapist could
provide speech perception training to accelerate outcomes of production-related treatments. Furthermore, by
applying more naturalistic measures of speech perception to this population, especially ones that rely on
participants to change over the course of a session, this project provides an innovative opportunity to examine
the sensory and perceptual consequences of PD and to link those to better-documented motor outcomes.

Public health relevance
Project Narrative Parkinson’s disease, a common movement disorder that results from a breakdown in the brain, often leads to challenges with talking, but less is known about the relationship between difficulties with talking and difficulties with learning to understand speech. By linking these two abilities in individuals with Parkinson’s disease using a precision medicine approach in line with the NIDCD’s strategic priorities, this project seeks to build a basis for new therapies that help people with Parkinson’s disease both understand better and speak more clearly.